Core A - Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE (CORE A)
In this competing renewal P01 application, the Administrative Core (Core A) will continue to provide critical
centralized grant administration, data processing, communication processing, and budget management for all
the projects and cores. This Core will also serve to amalgamate the investigators, their experimental findings
and their ideas, evaluation of research efforts and critically direct the summary efforts toward maintaining a
highly integrated program outcome. The Core functions are to: 1). Provide administrative services to the
investigators. This includes the management of project supplies, filing, development of memos, meeting
minutes and communications covering all operations, including publications; 2). Organize Program-related
meetings. Organize monthly or bi-monthly meetings/conferences of all PPG investigators; quarterly meetings
of the Program Steering Committee; annual meeting of the Internal/External Scientific Advisory Boards 3).
Maintain program integration activities. These include data sharing, rapid publication efforts, and identify
and institute other novel activities critical to maintaining and strengthening the integration of the program. 4).
Provide overall fiscal review, accounting, and real time budgets analyses. This includes reports, verbal
communications, reviews and forward-looking projections on expenditures.
This Core is essential for the program integration and effective communication of the scientific program.

Public health relevance
NARRATIVE The Administrative Core will provide centralized grant administration, communication processing, and budget management for the P01 projects and cores, and will facilitate the integration of the different clinical and technical components into a cohesive program that is focused on results.